Risk Stratification for and Early Detection of Liver Cancer

The Translational Research Center (TRC) includes a multidisciplinary team of clinical and translational
researchers that has a strong track record of collaborative work, with the collective mission of reducing the
burden of HCC. At the center of the proposed TRC lie two unique active prospective (in-HCC surveillance)
cohorts of patients with cirrhosis. One of the cohorts comes from a Cancer Prevention and Research Institute
of Texas (CPRIT) funded ongoing prospective multicenter study (Texas HCC Consortium) that is on target to
recruit > 3000 patients with cirrhosis (>12,000 surveillance episodes and 200 expected HCC cases) from
diverse etiologies (including cured HCV and non-alcoholic fatty liver disease). These patients are under routine
bi-annual surveillance at 5 medical centers in Texas. The second is a cohort of >700 patients (>1,300 visits
surveillance episodes and 33 incident HCC cases as of September 2017) recruited from and prospectively
followed at the Houston VA, most with cured HCV. The TRC will leverage, extend follow up, and harmonize
data and samples from both cohorts, collectively resulting in a > 23,000 episodes of HCC surveillance (and >
300 expected HCC) with bio-banked specimens, clinical and radiological data for each episode, rendering it an
invaluable resource for the proposed research and other trans-consortium projects. Using data from these
cohorts, we will develop and test novel personalized risk stratification indices for predicting the future ‐
development to HCC in patients with cirrhosis across diverse etiologies (Aim 1). We will also develop and
evaluate an early detection algorithm that combines existing HCC blood based biomarkers (e.g., AFP, AFP L3,
DCP), their longitudinal changes over time and select host features (age, etiology) in a phase 3 study. We will
also examine the performance of this algorithm in patients at different HCC risk strata (Aim 2). Our work will set
the framework for incorporating other patient and liver disease related factors into (new) biomarker profiles, an
area that is likely to remain highly relevant irrespective of the type of biomarker. We will evaluate highly
promising methylated DNA markers (MDMs, liquid biopsy) as an independent test for HCC risk prediction in
Aim 3. These markers have been identified in tissue case control phase 1 studies, reliable assays have been
developed and they have excellent performance for HCC detection in phase 2 studies. We will validate
individual markers in the study cohort and train an algorithm that combines the MDM to achieve maximum
performance. In a phase 3 biomarker study, we will validate the algorithm in the test sample overall and in key
subgroups based on HCC risk strata. Our approach (optimizing available markers while simultaneously
maintaining a strong forward outlook) will have both an immediate and long-lasting impact on HCC related
morbidity and mortality. The TRC will build on established and strong infra-structure and relationships to
complete the proposed research. It also represents a new and exciting avenue for collaboration with other
investigators within the U01 consortium.

Public health relevance
The Translational Research Center includes a multidisciplinary team of clinical and translational researchers who will leverage two unique active prospective (in-liver cancer surveillance) cohorts of patients with cirrhosis to develop and validate methods for risk stratification and early detection of liver cancer.